Commercialization of Optical Coherence Tomography with Advanced Optical Design and Adaptive Optics for Rodent Eye

Abstract
This project aims to develop and validate a novel Adaptive Optics Optical Coherence Tomography (AO-OCT)
system tailored for high-resolution, wide-field retinal imaging in small animal models, specifically mice. The
broad, long-term objective is to enhance our understanding of ocular diseases and neuronal dynamics by
providing researchers with a powerful tool capable of capturing detailed in vivo images of retinal structures. By
advancing imaging technology, this project seeks to contribute to the development of better diagnostic and
therapeutic strategies for retinal disorders.
Specific Aim 1 focuses on the development and optimization of a portable AO-OCT system with enhanced
imaging capabilities using a customized contact lens. This aim involves designing and fabricating an optical
system that integrates adaptive optics with a wide-field view of 150 degrees and a resolution of 2 microns. The
completion of this aim will be marked by the successful testing of the integrated system, demonstrating its ability
to reliably capture high-resolution images of photoreceptors and other retinal structures.
Specific Aim 2 is centered on the validation and optimization of the AO-OCT system using wild-type mouse
models. Initially, the system will be tested with a phantom eye model to evaluate its performance and refine the
design. Following this, validation will be conducted using wild-type mouse models to ensure the system's
reliability, reproducibility, and overall performance. Collaboration with Dr. Robert Zawadzki's lab at UC Davis will
support animal preparation and data acquisition. The expected outcome is the successful acquisition of high-
quality AO-OCT images with a 150-degree field of view and 2-micron resolution, validated through statistical
analysis and comparison with histological data.
The research design employs a combination of advanced optical engineering, adaptive optics integration, and
rigorous validation using both phantom models and live animal imaging. This project has the potential to
significantly advance the field of retinal imaging, providing valuable insights into retinal diseases and contributing
to public health by improving early diagnosis and treatment options for vision-related conditions.

Public health relevance
Narrative (Public Health Relevance) Our project aims to develop and validate a novel Adaptive Optics Optical Coherence Tomography (AO-OCT) system that significantly enhances imaging capabilities for studying retinal structures in mice. This innovative system will allow for high-resolution, wide-field imaging of photoreceptors, offering detailed insights into the retinal architecture and its response to various conditions. In the long term, this research could contribute to advancing our understanding of ocular diseases and neuronal dynamics, ultimately aiding in the development of better diagnostic tools and treatments that enhance health, extend life, and reduce disability related to vision disorders